Scientific and Technical Core

SCIENTIFIC AND TECHNICAL CORE: PROJECT SUMMARY
The Scientific and Technical Core (STC) provides the technological and methodological infrastructure that
enables Population Research Center (PRC) faculty scholars to achieve breakthroughs in population dynamics
research. Activities in this Core are organized around three aims. Aim 1 is to provide exceptional statistical and
data science services through a newly created Social and Behavioral Statistics and Data Science Hub. Aim 2
is to maintain a secure information technology infrastructure for data access and storage through the
Information Technology Hub. Aim 3 is to advance research innovation in the population sciences through a
series of workshops that will promote emerging research methodologies. This Core allows Faculty Scholars to
bring the ideas in their funded proposals from vision to reality by providing the technical and computational
infrastructure needed to collect, manage, analyze, visualize, and disseminate their findings.